Physiological and pathological functions of E3 ubiquitin ligases Smurfs

Smad ubiquitin regulatory factors (Smurfs) are members of the HECT family of E3 ubiquitin ligases. Two Smurfs, Smurf1 and Smurf2, were identified based on their activities to modulate TGF-beta/BMP signaling by promoting ubiquitin modification on Smads; however, subsequent studies have expanded the repertoire of Smurf substrates to include proteins such as RhoA, Runx2 and MEKK2 outside the TGF-beta/BMP pathway. To address the physiological function of Smurfs, we have generated mice lacking either Smurf1 or Smurf2. We found that these two paralogous E3 ubiquitin ligases have both common and unique functions during embryogenesis and in maintaining adult physiological homeostasis. Our earlier work on characterizing Smurf1 knockout mice revealed a novel mechanism in regulating osteoblast function and bone homeostasis, suggesting that targeting Smurf1 may prove to be an effective strategy for treating age-related bone losses in osteoporosis. Our recent analysis of Smurf1-/- mice showed that these mice were over-weight, obese, and exhibited glucose intolerance as well as insulin resistance; these are the clear signs of early stage non-alcoholic fatty liver disease (NAFLD). Our data indicated that Smurf1 catalyses the K63-linked non-proteolytic ubiquitin modification of peroxisome proliferator-activated receptor gamma (PPARg), thereby directly controlling the transcriptional activity of PPARg and the expression of its target genes to regulate lipid synthesis and fatty acid uptake. Our work on characterizing Smurf2 knockout mice clarified contradictory reports in the literature about Smurf regulation of TGF-beta signaling by showing that Smurf2 indeed has an inhibitory role, but it does so by attenuating Smad3 activity through mono-ubiquitination rather than promoting its degradation as previously reported. Using a murine incisional cutaneous model, we recently showed that Smurf2 affects inflammation and collagen processing in cutaneous wounds by down-regulating TGF-beta/Smad3 signaling. Because loss of both Smurfs leads to embryonic lethality, we have created a conditional Smurf2 knockout allele, which enabled us to investigate physiological functions of Smurfs by completely removal of all Smurf activities in desired tissues using tissue-specific expression of cre recombinase and obtain conditional Smurf null cells from late stages embryos or adult tissues. Our study of Smurf2 knockout mice also led to an unexpected discovery of a previously unrecognized function of Smurf2 as a tumor suppressor in the nucleus that is normally required to maintain genomic stability through regulation of DNA damage repair and chromatin compaction. We demonstrated that RNF20 is one of the Smurf2 nuclear targets in controlling DNA damage response and epigenetic landscape of histone modifications. To further understand how Smurf2 is recruited to DNA damage foci to regulate genomic integrity, we undertook a proteomic approach to identify Etoposide-induced Smurf2 interacting proteins and phosphorylation sites in Smurf2-/- MEFs reconstituted with Flag-tagged Smurf2. This led to the discovery of phosphorylation of Smurf2 at S384, an ATM consensus site. We subsequently showed that phosphorylation at S384 is required for Smurf2 to ubiquitinate and degrade RNF20, thus revealing a crucial molecular switch for the DNA repair activity of Smurf2. Consistent with the tumor suppresser function of Smurf2, we found that Smurf2 expression is decreased in the nucleus but increased in the cytoplasm of breast cancer cells. Smurf1 expression is also upregulated in the cytoplasm of the breast cancer cells. Overexpression of Smurf1 and Smurf2 promotes metastasis in nude mouse models and induces epithelial-to-mesenmchymal transition, migration, and invasion of breast cancer cells, suggesting that Smurfs play important roles in breast cancer progression. We are currently studying the mechanism underpinning the role of Smurf1 and Smurf2 promoting cancer cell migration and invasion.